SCREENING AND REFERRAL PRACTICES FOR CANCER DETECTION

This is a study of preventive health services in patients followed by primary care physicians within the Community Health Network in San Francisco. The study involves a three-year database search of colon cancer, screening practices, and other preventive health services including mammography, cholesterol, and prostate specific antigen. Investigators hope to identify factors involved with potential differences in health services utilization.